Neural Crest Development and Disease

Our recent work has focused on two main aims. First, we have studied early steps of neural crest development in the chicken embryo by using single cell level multiplex in situ hybridization approaches combined with genotype analysis following knockdown of genes of interest. Our work reveals interesting insight into the mechanisms of ectoderm patterning. Second, we have focused on validating methodology to recapitulate human neural crest development in vitro. These efforts will help us better understand the role of specific genes and molecular events during a certain developmental stage in normal human development as well as in neurocristopathies.